SAFETY &EFFICACY OF A NEW, HEAT TREATED INTRAVENOUS IMMUNOGLOBUIN PREPARATION

To study the safety and effectiveness of an IV new immunoglobulin preparation that has undergone heat treatment to reduce the likelihood of transmitting virus that causes hepatitis or other illnesses.